Application of pulsed focused ultrasound (pFUS) to deliver engineered therapeutic exosomes for the treatment of ischemic stroke

We have shown enhanced delivery of endothelial progenitor cell (EPC) derived naïve exosomes to the sites of
stroke using pulsed-focused ultrasound (pFUS) without causing damage to the surrounding brain tissues.
Preliminary results from the study also showed that enhanced delivery of EPC exosomes (by pFUS) caused
significantly decreased stroke volume and improved cerebral blood flow over 28 days compared to that of EPC
exosomes only treated animals. Therefore, pFUS without nanobubbles can be used as a method to enhance
the delivery of IV-administered exosomes at the site stroke.
We have developed a platform to make engineered exosomes using non-tumorous HEK293 cells that carry
and express specific cell-targeting peptides as well as therapeutic probes. The objectives of this proposal are
to develop engineered exosomes using our platform to carry neuron-specific rabies virus glycoprotein (RVG)
peptides as targeting ligands for the central nervous system and to carry a targeted therapeutic probe,
neuroglobin (Ngb), to protect neurons from hypoxic/ischemic and oxidative stress-related insults following
ischemic stroke. We hypothesize that engineered exosomes carrying both targeting RVG peptides and
therapeutic Ngb protein can be delivered to the site of ischemic stroke and the delivery of these exosomes will
be enhanced using pFUS to improve the benefits of post-stroke exosome therapy. The hypothesis will be
tested with the following specific aims:
Specific Aim 1: Investigate the characteristics of the engineered exosomes and in vivo biodistribution
of intravenously (IV) administered exosomes in stroke areas with or without pFUS.
Characteristics of the engineered exosomes will be investigated to determine the size, zeta potential, and the
presence of peptide and protein on the surface or inside the lumen using techniques as per our published
methods. Then biodistribution of exosomes carrying Ngb on the surface or in the lumen ±pFUS will be
determined using In-111-tagged respective exosomes at the sites of stroke by SPECT-CT. We will also
determine the distribution of exosomes with or without RVG peptides.
Specific Aim 2: Investigate the recovery from a stroke following delivery of engineered exosomes
carrying Ngb with or without pFUS.
Exosomes will be delivered by pFUS after 24hrs of stroke; stroke recovery will be determined using MRI, and a
battery of short- and long-term behavioral outcome tests will be performed followed by immunohistochemistry
on brain tissue samples.

Public health relevance
Recent investigations showed a positive outcome in ischemia-reperfusion stroke following administration of non- engineered non-targeted (naïve) exosomes collected from different stem cells. The objectives of this proposal are to develop engineered exosomes to carry rabies virus glycoprotein peptides on the surface of the exosomes and to carry neuroglobin either on the surface or in the lumen of the exosomes, and use these exosomes to treat ischemic stroke. Pulsed focused ultrasound will be applied to enhance the accumulation of these engineered exosomes to the site of a stroke.